Senescence and Salivary Gland Dysfunction

ABSTRACT
Hyposalivation can result from the normal aging process, a side-effect of radiation therapy (RT), and a symptom of
autoimmune disease leading to a variety of negative sequelae including increased incidence of dental caries, halitosis, and
reduced digestive function. Sjögren’s Syndrome (SS) is an autoimmune exocrinopathy affecting the salivary glands,
lacrimal glands, and other exocrine organs in 0.4% of the US population, with most patients being women over 40 (9:1
female to male ratio). The primary deficit underlying SS is the loss of functional secretory epithelium in exocrine glands.
The mechanisms leading to loss of function are complex and multifactorial but include both immune-dependent and
immune-independent pathologies that extend to normal aging and RT. Cellular senescence is an important tumor-
constraining mechanism that halts cellular proliferation and has positive impacts on wound healing but, when activated
chronically, can exacerbate tissue injury and loss of function. Recent work demonstrated that senescent cells accumulate in
the salivary glands of SS patients, because of RT, and during normal aging. How cellular senescence contributes to salivary
hypofunction in SS and other conditions is incompletely understood. Senescent cells that accumulate with age adopt a
senescence-associated secretory phenotype (SASP) characterized by the secretion of cytokines, growth factors, and
proteases that disrupt tissue homeostasis and contribute to age-related pathologies. SASP is causally linked to tissue
degeneration by paracrine effects on neighboring cells, and genetic ablation of senescent cells can preserve organ function
by limiting SASP. Similarly, senolytic drugs that systemically ablate senescent cells can increase general health and lifespan
in mice. Minimization of SASP may limit the amplitude and duration of the inflammatory response, restrict the loss of
exocrine function, and delay disease-related organ decline. We have identified several microRNAs that control SASP and
inflammatory cytokine gene expression that can be used as targets to limit the activity of senescent cells. The studies detailed
here will test the hypothesis that senescence promotes non-resolving inflammation in SS-like disease to drive salivary gland
hypofunction. We will test our hypothesis by selective modulation of the senescence program in both organoid-based and
murine models of salivary gland hypofunction. We propose to address the following specific aims: 1. Define the
contribution of senescence- and Sjögren’s Syndrome-associated miRNAs in SASP regulation. Aim 2. Determine if
ablation of senescent cells or targeting of miRNAs promoting SASP can reduce non-resolving inflammation and
fibrosis in vivo. 3. Define the contribution of the senescent cell SASP to SS disease development. This study will further
our understanding of the link between senescence, inflammation, and salivary gland hypofunction. Studies comparing
genetic and RNA-mediated methods for senescent cell abatement and antagomiRs for SASP phenotype modulation will
reveal potential RNA-based therapeutic strategies for the functional restoration of salivary glands of SS patients and other
aged or injured organs.

Public health relevance
NARRATIVE Sjögren’s Syndrome is an immune disorder in which the function of the moisture-secreting glands of the eyes and mouth is reduced, resulting in “dry mouth” and “dry eye,” where risk increases with age. Cellular senescence is a process by which normal cells stop dividing and produce molecules that can stimulate inflammation, which is linked to a decline in organ function with age. The studies proposed here will define whether potential RNA-based therapeutics which block cellular senescence will prevent loss of fluid secretion from the moisture-secreting glands of the mouth in experimental models of fibrosis/inflammation and Sjögren’s Syndrome, processes commonly observed during the normal aging process and in response to radiation therapy for head and neck cancers.